Development of a web-based platform implementing novel Predictor of Toxicity for Medical Devices (PredTox/MD)

1 Medical devices contain chemicals that can leach and cause adverse effects. International standards (ISO
2 10993) require the evaluation of such chemicals for specific toxicity endpoints, including skin sensitization,
3 irritation, and cytotoxicity. Short-terms assays commonly used for this task are time-consuming, expensive, and
4 require the sacrifice of many animals. Emerging FDA directives call to restrict and, eventually, eliminate animal
5 testing of medical and cosmetic products and develop alternative methods including computational tools. To
6 address this unmet need, in Phase I of this project we have created the largest carefully curated and publicly
7 available Guinea Pig Maximization Test (GPMT) dataset and developed first-in-class machine learning models
8 that predict the GPMT outcome. We implemented our models within the fully operational Predictor of Skin
9 Sensitization for Medical Devices (PreSS/MD) web portal. In Phase II, we will create new models and software
10 modules for reliable assessment of chemicals found in medical devices for sensitization, irritation, and
11 cytotoxicity per ISO 10993 guidance. These modules will be both available for licensing as standalone tools or
12 web applications as well as integrated into novel Predictor of Toxicity for Medical Devices (PredTox/MD) web
13 portal. The proposed R&D studies are structured around the following Specific Aims: Specific Aim 1: Develop
14 a highly curated, comprehensive PredTox/MD database. We will collect, thoroughly curate, and integrate
15 public data for all human, in vivo, and in vitro regulatory assays for skin sensitization, irritation/corrosion, and
16 cytotoxicity. We will extend our database to include all available data on chemical mixtures and develop special
17 curation workflows to handle mixtures of any composition. Specific Aim 2: Develop validated computational
18 models to predict sensitization, irritation, and cytotoxicity for chemicals leaching from medical devices.
19 We will employ our widely accepted predictive Quantitative Structure-Activity Relationship (QSAR) modeling
20 workflow fully compliant with OECD model validation principles. Consensus ensemble models will be developed
21 with several descriptor types and machine learning algorithms, including deep and active learning and a
22 Bayesian model integrating multiple individual assay models to predict the overall chemical safety. Specific Aim
23 3: Develop software modules for assessing medical device toxicity and incorporate these modules into
24 PredTox/MD portal. Models and workflows developed in Aim 2 will be programmed as autonomous software
25 modules that will be integrated into PredTox/MD platform and available for individual licensing to enable rapid
26 multi-point toxicity assessment for extractables and leachables found in medical devices. Successful
27 completion of Phase II studies will result in the novel computational toolkit and web-based resource to
28 evaluate toxicity of medical devices as required by ISO 10993 guidance.

Public health relevance
There are emerging FDA directives to restrict and, eventually, eliminate animal testing of medical and cosmetic products and integrate alternative New Approach Methods (NAMs) into regulatory programs. However, such evaluation still relies on time-consuming and expensive animal testing. To address this yet unmet need, in Phase II of this project, we will create novel computational toolkit and web-based resource to evaluate the toxicity of medical devices for sensitization, irritation, and cytotoxicity.